Biophysical properties of lymph nodes in aging

Summary
Aging reduces our bodies’ ability to respond to pathogens and vaccines. This is thought to at least in part be due
to impaired functions of adaptive immune cells, which are educated and activated in the lymph nodes. The lymph
nodes are highly organized tissues that coordinate T and B cell (the primary adaptive immune cell) functions
through a complex system of interactions and migration within the tissue. Recent work has shown that T cell
migration and motility is impaired in aging, and that this is correlated to the age of the lymph node tissue
specifically, not the age of the T cells. Interestingly, researchers have demonstrated that during aging
extracellular matrix materials and adipose tissue is accumulated in the lymph nodes. Changes in the composition
of lymph node tissue may result in changes in its biophysical properties like elastic and viscous moduli, as well
as stiffness. An increase in stiff adipose tissue and more fibrous material is likely to increase the tissue’s elastic
modulus and stiffness. Adaptive immune cells have been shown to respond poorly to increases in stiffness and
elastic modulus, as indicated by a reduced ability to migrate in proximity to extracellular matrix materials and
impaired activation in stiff environments. Thus far, no studies have been able to correlate these structure-function
relationships in the lymph node. This is likely due to the difficult nature of extracting biophysical properties like
elastic and loss moduli and stiffness from small tissues, while maintaining tissue integrity, and correlating these
properties to different regions of a tissue. We have pioneered the use of multiple particle tracking (MPT) and
Brillouin microscopy to study lymph node biophysical properties ex vivo via tissue slice cultures. MPT
uses nanoparticle Brownian motion within a tissue to extrapolate its elastic and viscous moduli, pore size, and
viscosity and we have used this method to assess biophysical properties of T and B cell regions of skin and
mesentery lymph nodes. Brillouin microscopy uses interactions between inherent and incident phonons to
calculate a shift that can estimate the uniaxial stress-strain ratio at high frequency, resulting in a heat map of
moduli that are correlated with the tissue’s elastic modulus. Here, we will correlate the biophysical properties
obtained through both of these methods with extracellular matrix and lymph node compartments using
immunofluorescence to provide a complete picture of how the lymph node structure impacts local properties in
the context of aging. We will also assess how specific extracellular matrix components, such as different
collagens, contribute to lymph node biophysical properties. Altogether, our proposed studies will build key
knowledge in our understanding of how lymph node structure affect their biophysical properties and will lay the
foundation for future investigations of structure-function relationships between lymph node biophysical properties
and T and B cell behavior and function in the context of aging.

Public health relevance
Narrative Aging impairs immune cell functions, which causes a reduction in our ability to fight off pathogens. Research has shown that aging causes accumulation of fibrous extracellular matrix material in the lymph nodes, which may change the biophysical properties of the tissue, and immune cell functions have been shown to be impacted by these biophysical properties. Here, we investigate how lymph node biophysical properties change in aging, which has not been investigated.